5/8 INIA Stress and Chronic Alcohol Interactions: Probing brain circuits that regulate alcohol stress interactions

Project Summary
In this project we will mechanistically explore two neuromodulatory systems within the extended
amydala and how they regulate plasticity and behavior following alcohol exposure and stress. In
particular, in aims 1 and 2 we will utilize novel CRISPR technology to manipulate signaling in discrete
brain regions, building on our prior investigations. In aim 1, we will explore the role of central amygdala
(CeA) Kappa Opioid Receptor (KOR) signaling in alcohol and stress driven alterations in plasticity and in
vivo dynamics of specific bed nucleus of the stria terminalis (BNST) outputs. In aim 2, we will investigate
the contribution of noradrenergic signaling to alcohol drinking and alcohol driven disruptions of
behavior. In aim 3, we will collaborate within and across INIA consortia in three ways (i.) investigating
how CeA KOR knock out regulates alcohol exposure induced disruptions of dopamine signaling in vivo
(Jones/Holleran component) , (ii.) investigating adrenergic receptor modulation in the BNST following
alcohol consumption (Grant/Schnitko), (iii.) whole brain cFos analysis following GPR88 agonism to
reduce alcohol consumption (Kieffer/Harsan). Thus, these integrated, yet independent aims, will provide
circuit specific mechanistic findings in critical nodes that have been established to contribute to multiple
aspects of the positive and negative reinforcing properties of alcohol.

Public health relevance
Alcohol use disorder (AUD) affects approximately 14.1 million people in the United States. Despite the prevalence of this disorder, we lack a thorough understanding of its underlying neurobiological mechanisms. Here, we propose to use a multi-faceted mechanistic investigation to being to unravel the role of extended amygdala neuromodulatory action in AUD.